Artificial Intelligence Passport for Biomedical Research: Digital Experiential Learning Community for Upskilling in Artificial Intelligence for Biomedical, Behavioral and Clinical Research

Project Summary/Abstract
The University of Florida (UF) proposes to develop a nation-wide digital course to upskill biomedical researchers’
expertise in artificial intelligence (AI). The AI Passport for Biomedical Research (AIPassportBMR) overall
objectives are to provide diverse biomedical researchers the opportunity to augment their skills in a concise and
comprehensive course based on innovative learning techniques and will be the first scalable, self-correcting AI
training program that is dynamic enough to withstand constant evolution of AI technologies. AIPassportBMR will
focus on technical skills while providing mentorship on how to expand biomedical research into the AI field with
highly collaborative sessions that include national leaders in medical AI. Moreover, due to the disparity in the
current AI workforce, participants will be selected to increase diversity and inclusive excellence. Biomedical
research and AI each align with institutional priorities, possess robust resources, and represent highly
collaborative and successful scientific communities at UF. Designed as a digital experiential learning community,
this program will enable predoctoral trainees and early-stage investigators in biomedical, behavioral, and clinical
sciences to acquire the multidisciplinary skills necessary to integrate AI into their research while creating a
nationwide community of likeminded mentors and peers. Our approach aligns with the objectives outlined in the
IPERT initiate to provide skills development and mentoring to an inclusive audience through the following three
overarching aims: Aim 1. AIPassportBMR Program: Develop the educational and technological infrastructure for
community-driven experiential biomedical AI training using a See-Practice-Share-Reflect learning approach, Aim
2. Real-World Evaluation: Implement, evaluate, and fine-tune AIPassportBMR using an implementation mapping
framework and Cognitive Theory of Culture to align instructional design with learners’ subcultural and educational
needs, Aim 3. AI Digital Community of Practice: Build a support mosaic network of peers, mentors and coaches
and the capacity for sustainable nationwide dissemination of the AI research training program.
To further expand AIPassportBMR, the digital community learning platform program will be disseminated
nationwide to build capacity for biomedical AI workforce development and support replication for all biomedical
researchers. This program is committed to promoting diversity and inclusive excellence for its participants.

Public health relevance
Project Narrative As artificial intelligence (AI) becomes an ever increasingly component of biomedical research the need for an inclusive trained workforce is essential. The University of Florida (UF) proposes to develop a nation-wide course to upskill biomedical researchers’ expertise in AI while promoting diversity and inclusive excellence for its participants through career development and mentoring. The AI Passport for Biomedical Research (AIPassportBMR) proposal will provide biomedical researchers the opportunity to augment their skills in a concise and comprehensive course based on innovative learning techniques while being mentored by AI experts from across the nation.